Cortical mechanisms and modulation of somatosensation in older adults with foot sole somatosensory impairments

PROPOSAL SUMMARY
My career goals are to 1) understand the supraspinal sensorimotor pathways through which age- and age-
related conditions diminish the functionality of the locomotor control system, and 2) use this information to
develop new therapies to improve gait and balance in older adults. I hope to achieve this goal by transitioning
into an independent scientist and leading an research program in the fields of aging and balance control.
In older adults, diminished lower-extremity somatosensation is highly prevalent and a primary contributor
to poor balance, reduced mobility, and increased risk of falling. The vast majority of research and clinical efforts
to date have attempted to improve somatosensation by restoring the function of peripheral elements of the
somatosensory system. However, somatosensation is also dependent upon the capacity to activate the
appropriate cortical networks in response to a given stimulus, which is also altered in older adults. Therapeutic
strategies aimed at enhancing the excitability of the somatosensory cortical network thus offer untapped
potential to improve foot-sole somatosensation in this population. Our preliminary studies suggest that a single
session of traditional transcranial direct current stimulation (tDCS), which produces a diffuse electric field over
the primary somatosensory cortex, improves foot-sole somatosensation in older adults. In this K01 Award, we
will first work to identify the specific cortical network that is responsive to walking-related foot-sole stimulation
in older adults with and without foot-sole somatosensation (Aim 1). We will use a block-design functional MRI
paradigm with a custom-designed, MRI-compatible foot sole stimulation system to apply individualized
pressures to the participant’s foot soles that mimic those experienced when they walk, yet while they lay
motionless in the scanner. Based upon this knowledge obtained from Aim 1, we will develop a novel multi-
target tDCS intervention targeting the identified cortical network and test the effects of a single session of this
intervention on foot-sole somatosensation, balance and mobility in older adults with mild-to-moderate foot-sole
somatosensory impairments (Aim 2). We will then use participant brain MRIs and electric field modeling to
establish the “dose-response” relationship between on-target current intensity induced by tDCS and its acute
effect on the cortical response to foot sole stimulation (Aim 3). Through this work we will learn about how
chronic lower-extremity somatosensory impairments influence the cortical processing of sensory feedback
involved in the control of balance and mobility, demonstrate that such processing can be modulated by tDCS,
and thus, obtain critical information needed to design a larger more definitive trial to test the potential for tDCS
to improve foot sole sensation, balance, and mobility in this population. This career development award will
provide me with unique training experiences in neurophysiology of somatosensation in aging, the clinical care
of these older adults, and increase my expertise in advanced neuroimaging and brain stimulation techniques,
which, taken together, will greatly facilitate my efforts to transition into an independent academic scientist.

Public health relevance
Project Narrative In older adults, diminished sensation of the legs and feet is highly prevalent and causes poor balance and reduced mobility. This type of sensation is not only dependent upon the receptors and nerves in the legs and feet, but also upon a complex central nervous system pathway that includes the cerebral cortex of the brain. This project will use a form of noninvasive brain stimulation called transcranial direct current stimulation (tDCS) to test whether increasing the excitability of the brain networks that process sensory feedback can augment foot sole sensation, balance, and mobility in older adults suffering from mild-to-moderate foot sole sensory impairments.